Dissecting roles of inputs and recurrent connectivity in motor cortex

The overarching objective of the proposed research is to dissect how primary motor cortex (M1) flexibly controls
different types of movements in the macaque monkey. In primates, M1 is a necessary structure for the generation
of voluntary limb movements, like reaching towards your phone and then grasping it. M1 appears to operate
under distinct computational modes in reaching and grasping. During reaching, neural population dynamics, that
is the time-varying pattern of firing rates in populations of neurons in M1, are low-dimensional and with a specific
structure (“rotational”). In contrast, neural population dynamics during grasping are high-dimensional and not
rotational. The goal of this specific proposal is to understand how M1 can exhibit these different computational
modes. My overall premise is that these diverse operating modes of M1 emerge due to relative contributions of
two key components: autonomous recurrent dynamics within M1, and external inputs from other brain areas.
Here, I will test my central hypothesis that M1 activity during reaching is controlled primarily by strong recurrent
dynamics, whereas grasping is dominated by inputs in two Aims. In Aim 1, I will train monkeys to perform two
different tasks: a delayed reaching task, and delayed grasping of various objects (using a turntable). I will use
high-density electrophysiology (Neuropixels) to measure the neural population dynamics in M1 and two areas
that provide input to M1 (dorsal premotor cortex (PMd) and primary somatosensory cortex (S1)) during these
tasks. I will then use residual dynamics analysis techniques to identify the dynamical landscape and inputs to
M1 underlying reaching and grasping. The residual dynamics approach models M1 neural population activity as
a dynamical system and uses trial-to-trial variability to distinguish between input-driven (e.g., rotations with
minimal inputs) versus recurrence-driven (e.g., moving point attractors) systems. I will test the hypothesis that
M1 dynamics during reaching are better explained by models with recurrent dynamics within M1, whereas those
during grasping are better explained by models that leverage inputs from other areas. In Aim 2, I will use causal
approaches to further test the hypothesis. I will express red-shifted opsins in inhibitory neuron populations of
PMd and S1. I will then stimulate these inhibitory neurons one at a time to silence the area, while recording from
M1 as the animals perform the reaching or grasping task. I will then assess the impact of this optogenetic
silencing on (PMd/S1) on both behavior and M1 neural dynamics. My hypothesis is that silencing input areas will
have stronger impact on both behavior and M1 dynamics during grasping than reaching. Collectively, the two
aims will dissect the roles of inputs versus recurrence in M1 dynamics across multiple tasks and illuminate how
M1 operates under dramatically different modes to flexibly control arm and hand movement behavior. Impact:
The proposed work understands how M1 in concert with other clinically relevant brain areas flexibly controls two
fundamental behaviors: reaching and grasping. Such an understanding will enable the development of better
brain-computer interfaces and circuit-level interventions for stroke, cortical injury, and neurological disorders.

Public health relevance
PROJECT NARRATIVE Stroke, cortical injury, and neurological disorders often impact the premotor and motor cortex, and lead to deficits in reaching and grasping. The proposed research uses correlative electrophysiological, computational, and causal optogenetics approaches to advance our understanding of how the motor system in macaque monkeys, a species closely related to humans, mediates motor control. Such fundamental advances will inform the design of the next-generation of brain-machine interfaces and circuit-level interventions for patient populations.